TOBACCO REDUCTION IN AN HMO--A MODEL FOR CANCER CONTROL

This program project grant application proposes five individual projects supported by three core components and an administrative unit. The five projects address how tobacco use can be modified in a Health Maintenance Organization (HMO). They are designed to identify cost-effective approaches to Phase III cancer control projects and to determine whether the proposed approaches can be adapted as Phase IV population-based interventions. This program project is a joint effort by the Center for Health Research (CHR) at the Kaiser Foundation Hospitals in Portland, Oregon and the Oregon Research Institute (ORI) in Eugene, Oregon.